Neural Circuit Mechanisms of Stress-Impaired Social Reward

Abstract
Alzheimer's disease (AD) is characterized by neurodegeneration of the brain that is associated with intraneuronal
neurofibrillary tangles, extracellular neuritic plaques and neuroinflammation. Synaptic alteration or dysfunction
is increasingly viewed as one of the earliest events in the initiation of AD-type cognitive decline preceding
neuronal loss. Aside from cognitive and memory impairments, AD is also commonly associated with social
behavioral abnormalities and psychological symptoms. It is estimated that approximately 80-90% of dementia
patients suffer from behavioral disorders that include apathy, depression, irritability, agitation, anxiety, social
withdrawal, social disinhibition, aggression and agitation. These behavior problems can have a huge impact on
the quality of life of the patients and their caregivers. While the mechanisms of comorbid neuropsychiatric
symptomswith AD are not well known, it is postulated that neurodegeneration in AD disrupts the brain circuitries
involved in social behavior and emotion. Under the parent R01, my lab has been investigating the neural
circuitries mediating chronic stress-induced social behavior alteration. We have shown that social stress induces
occlusion of social reward and preference in stress susceptible mice and it is associated with aberrant activation
of neurotensin (NT)-positive GABAergic neurons in the lateral septum (LS). We also found that chemogenetic
activation of LSNT neurons promotes social avoidance behavior and reduced social reward in stress resilient
mice, suggesting LSNT neurons plays an important role in determining responses to social rewards. In several
genetic mouse models that recapitulate aspects of AD neuropathology, impairments in social behavior have also
been observed. In a well-established 5xFAD mouse model of AD-related pathology, we confirm that these mice
exhibit deficits in social reward. Thus, in this supplement, we propose to longitudinally examine the activity of LS
circuit during social interaction in the 5xFAD mice to determine whether AD-associated reduced social
preference is driven by LSNT neurons. Moreover, as it is well established that social stress exacerbates
neuropsychiatric symptoms in AD, we will also test the effect of social defeat stress on LS circuit activity and
social behavior in 5xFAD mice.

Public health relevance
Narrative: Stress in humans increases the risk for developing Alzheimer's Disease (AD) and results in significant impairments in social behavior. Here we will use mouse model of AD-related pathology to test the interaction between stress, AD-genotype and circuit dysfunction controlling social behavior deficits. Our results will provide critical insight into the neural circuit deficits responsible for AD-related social behavior deficits.